Ectopic X-chromosome inactivation is critical for limb patterning

ABSTRACT
Morphologically and functionally appropriate limb development is critical for quality of life. There is compelling
evidence that growth factors, including Bone Morphogenetic Proteins (BMPs), regulate limb development.
However, the mechanism of how growth factor signaling is involved in early patterning of mesenchymal
condensation and subsequent cell fate specification in mesenchymal stem/progenitor cell population remains
unclear. We recently found a formation of massive ectopic cartilage in the craniofacial region of a mutant
mouse line engineered to augment BMP-Smad signaling in a neural crest-specific manner. During preliminary
characterization, we made three interesting findings: 1. augmented BMP signaling in cranial neural crest cells
(NCCs) results in an increase of Xist expression, a non-coding RNA critical for X chromosome inactivation,
(XCI) leading to ectopic XCI in cranial NCC-specific manner, 2. the ectopic XCI is functionally essential for
ectopic cartilage formation, and 3. transient upregulation of Xist expression and ectopic XCI are found in
wildtype limb development. Based on these experimental data, we hypothesize that transient ectopic XCI is
an unappreciated unique mechanism essential for limb development during early mesenchymal condensation
and subsequent skeletogenesis.
We will fully utilize mutant mouse lines generated in our laboratories and ones from our collaborators,
and unbiased bioinformatics approaches to test the hypothesis. In Aim 1, we will uncover the landscape of how
differentially suppressed genes by ectopic XCI in a spatial-temporal manner. In Aim 2, we will identify the
functions of ectopic XCI during limb development. Our preliminary data using limb bud ex vivo culture suggest
that ectopic XCI is involved in early mesenchymal patterning.
Our unique experimental tools and approaches will allow us to determine the role of BMP signaling in
mesenchymal patterning and subsequent cell fate specification in limb development. Completing the proposed
study will generate a novel knowledge informative to understand unique mechanisms of limb patterning and
thus provide new insight for better treatment options for congenital limb abnormalities and directions toward limb regeneration.

Public health relevance
PROJECT NARRATIVE Abnormal limb development significantly impacts the quality of life, and thus, a better treatment option to prevent malformation and a possible future application for regeneration of malformed limbs are awaiting. Here, we will investigate a novel mechanism of how multipotent stem/progenitor cells commit their cell fate towards chondrogenic lineage, specifically the unique mechanism of ectopic X chromosome inactivation induced by BMP signaling. The proposed experiments will deepen our knowledge of unexplored connections of limb development and regulation of cell fate through this novel mechanism, offering hope for the development of better strategies to prevent and treat limb malformations.